Determining the Architectures and Activities of Polyketide Synthase Modules

A renaissance in the field of modular polyketide synthases has begun. New tools and paradigms are enabling
deeper insights into the architectures and activities of these enzymatic assembly lines and are facilitating our
long-term goal of applying the synthetic power of modular polyketide synthases to the development and
production of new medicines. Using the updated definition of the “module”, our lab has engineered diverse tri-
/tetra-/pentaketide synthases that are functional both in vivo and in vitro. While these short assembly lines are
uncommon in nature, they are ideal for our structural and functional studies. In Specific Aim 1 we propose to
plunge-freeze these assembly lines as they are synthesizing their polyketide products and investigate them by
cryo-electron microscopy. Since this approach has enabled us to capture high-resolution, dynamic information
of the priming ketosynthase and acyltransferase of a model triketide synthase, we will apply it to synthases that
contain other regions of interest. One objective is to learn how the ketoreductase, dehydratase, and
enoylreductase processing enzymes are oriented relative to one another and the neighboring
ketosynthase+acyltransferase didomains to understand how acyl carrier protein domains move between these
enzymes during the extension and processing of polyketide intermediates. Thus, we will investigate at least
thirteen engineered tri-/tetraketide synthases and two natural synthases functionally validated in our lab that
contain different sets of these processing enzymes. In Specific Aim 2 we propose to elucidate interactions
between processed polyketide intermediates and the ketosynthases that gatekeep for them. We have strong
hypotheses for how sets of substrate tunnel residues interact with intermediates closest to the reactive thioester
to ensure they are properly modified by upstream processing enzymes. Thus, we will appropriately mutate the
gatekeeping residues of ketosynthases in less active model synthases as well as model synthases with
inactivated upstream processing enzymes and determine whether their productivities improve as predicted.
Since our data indicate that polyketide intermediates rigidify the ketosynthase dimer and dimeric
ketosynthase+acyltransferase didomains can be readily identified in cryo-electron microscopy studies, we will
also perform electron microscopy on stalled synthases to solve structures of polyketide-bound
ketosynthase+acyltransferase dimers. In Specific Aim 3 we propose to determine key domain-domain interfaces.
We have evidence that interfaces between processing enzymes and downstream KSs drive the ordered self-
assembly of synthase polypeptides more than the small interface observed between the C- and N-terminal
docking domains and seek structures of representative complexes. We also aim to determine how acyl carrier
protein domains dock with ketosynthases during the transacylation reaction. If we are successful in these
projects, it will greatly inform the rational engineering of modular polyketide synthases that synthesize new
molecules and, ultimately, new medicines.

Public health relevance
Modular polyketide synthases are enzymatic assembly lines that aid in the production of human medicines ranging from antibiotics to anticancer agents. In order to engineer them to help in the development and production of new medicines, more must be learned about how they are organized and how they operate. We are making these discoveries with the help of powerful electron microscopes and model assembly lines produced in our lab.